Integrative Health Sciences Facility Core

The Integrated Health Sciences Facility Core (IHSFC) facilitates multi-directional mechanistic, toxicological,
and clinical translational as well as population-based studies and public health policy and education, with a
focus on the environmental exposures affecting human health that are unique to the diverse populations of the
Southwest. The mission of the IHSFC stems from the three SWEHSC research themes: environmental
exposures in underserved Southwest populations, environmental lung disease, and adaptive responses to
environmental stressors, which span a number of environmental exposures including organic solvents, metals
and metalloids, airborne particulate matter, and UV light exposure. To foster integrated environmental health
research, the IHSFC is organized around three operational components. The Human Populations and
Exposure Resource provides strategic advice and resource support to SWEHSC investigators sampling
southwest human populations and their living environment, and in communicating research findings with key
stakeholders. The Data Science Resource provides statistics, bioinformatics, database development and
integration, and high-performance computing support and resources to investigators within a model of project
partnership. The Emerging Contaminants Analytical Resource provides analytical capabilities and technical
expertise to detect and quantify organic and inorganic contaminants of concern in complex environmental and
biological matrices. By combining these three resource areas, the IHSFC provides integrated services and
expertise in environmental exposure measurement and modeling, the analytical measurement of
environmental and biological samples and exposure biomarkers, and in the use of those measurements to
model the relationship between exposure and health outcomes. IHSFC scientists work with investigators from
all three SWEHSC research focus groups (RFGs) and Pilot Projects, serve as mentors for Career
Development beneficiaries, and work with the Cellular Imaging and Genomics Facility Cores to ensure
consistent, professional statistics and bioinformatics study design, data management, and connectivity. Finally,
the IHSFC collaborates extensively with the Community Engagement Core (CEC) to leverage established
relationships with community stakeholders, identify exposures of concern to communities, assess
environmental health literacy, and identify effective strategies for communicating research results and
environmental risk to the people of Arizona and the Southwest.